SEQUENCE DETERMINANTS OF PROTEIN STRUCTURE AND FUNCTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are studying how AAA+ enzymes including ClpXP, HslUV, and Lon catalyze ATP-dependent denaturation and subsequent degradation of specific target proteins.